Exposing the Functional Role of Novel Protein-RNA Interactions in PRC1 During Development

Project Summary
The goal of this proposal is to dissect the distinct molecular roles of protein-RNA interactions between RNA
and the Polycomb Repressive Complex 1 (PRC1) during neural differentiation. PRC1 is a conserved chromatin
modifier that represses transcription via chemical and structural alterations of chromatin architecture. PRC1
mutations cause neurodevelopmental disorders characterized by microcephaly, intellectual disabilities, and
dysmorphic body features, making it crucial to gain understanding about PRC1 function. Despite its ubiquitous
expression, PRC1 can target distinct sets of genes for silencing in different cell lineages, resulting in cell-type
specific expression. Though there are decades of research on Polycomb protein function, a key unanswered
question is how PRC1 selects different target genes in different cell types. Mounting evidence in the field
indicates that major epigenetic events are regulated by interactions between RNA and chromatin-modifying
proteins, including subunits of PRC1. However, PRC1-RNA interactions remain underexplored.
My preliminary data indicates that at least two PRC1 subunits, SCMH1 and RING1B bind to RNA in vivo. I will
investigate the regulatory role of these protein-RNA interactions in the context of directed differentiation of mouse
embryonic stem cells (ESCs) into neural progenitor cells (NPCs) with the following specific aims.
In Aim 1, I will identify RNAs directly bound to SCMH1 and RING1B in pluripotent ESCs using state-of-the art
photocrosslinking and sequencing approaches. I will also map protein residues required for these interactions
using a new technology that couples genetically encoded peptide barcodes to a mutational library for each
subunit followed by a mass spectrometry readout.
In Aim 2, I will investigate the functional roles of these protein-RNA interactions during neural differentiation by
using our existing RNA-binding PRC1 mutants and a degrade-and-rescue approach, leveraging my lab’s
expertise in acute protein degradation. The experiments in this proposal will provide the first in-depth
characterization of PRC1-RNA interactions in regulating cell fate transitions during differentiation.
To achieve these aims, I have developed with my sponsor and co-sponsor a rigorous and comprehensive
training program with four primary goals: 1) become an expert in mass spectrometry for protein-RNA
biochemistry, 2) gain experience in cutting-edge functional genomics methods, 3) increase proficiency in
bioinformatics and data analysis, 4) sharpen my research communication skills.
I am confident that my choice of sponsor and co-sponsor combined with my diverse training background and
the collaborative nature of my training environment will enable me to achieve my goals and the proposed
research plan simultaneously.

Public health relevance
Project Narrative The Polycomb Repressive Complex 1 (PRC1) is a conserved epigenetic regulator that is required for proper development, and its dysregulation is linked to abnormal embryogenesis, various cancers, and neurodevelopmental disorders. Multiple PRC1 subunits interact with RNA, but the role of these interactions in development is unknown. I will employ a new protein-RNA mapping technology as well as acute protein degradation during differentiation of mouse embryonic stem cells to obtain mechanistic insight into the role of PRC1-RNA interactions in regulating cell fate transitions during developmental transitions.